Contribution of Longitudinal Neighborhood Determinants to Cognitive Health and Dementia Disparities within a Multi-Ethnic Cohort

PROJECT SUMMARY
Disasters create widespread disruption across all societal systems. With climate change, the number and
intensity of disasters is increasing. Existing research supports a disproportionate impact of disasters among
the growing population of older adults. Furthermore, likely heterogeneity in these disaster impacts by
individual- and community-level characteristics may exacerbate racial and socioeconomic disparities in health
outcomes among this population, such as cognitive decline. This necessitates identification of specific
characteristics that influence risk for poor cognitive outcomes related to disaster impact. Neighborhoods offer
the opportunity to address disparities by building up community resilience to disaster. Access to supportive
neighborhood environments, including places where people come together to interact to build connections,
are necessary for coping with disasters. By understanding community changes that mitigate cognitive
disparities, we can improve disaster response policies and programs to support institutions that create positive
health effects and reduce disparities in cognitive health.
This 1-year project will augment a currently funded R01 to identify factors that prevent disaster-related
cognitive impairment among older adults. We will integrate quantitative data on disaster exposure from Spatial
Hazard Events and Losses Database for the United States (SHELDUS) and community-level resilience from
surveys and geographic information systems (GIS) data with individual-level risk factors and health outcomes
from the MESA and REGARDS cohorts. To measure and describe climate-related disaster and community
resilience over 20 years, we will compute metrics of disaster impact (months, severity) and indicators of access
to diverse neighborhood institutions (density, diversity). These data will be linked to the 6,814 MESA
participants and 30,107 REGARDS participants (Aim 1). Using longitudinal health data in both cohorts, we will
estimate the magnitude of disaster-related cognitive impairment and the community-resilience factors that
quantitatively mitigate risk (Aims 2 & 3). We will use the geographic and racial/ethnic diversity of the cohorts to
understand individual- and community-disparities in disaster impact and disaster-related cognitive impairment.
These findings will result in refined measures of resilience to inform interventions that build disaster resistance
and recovery, and ultimately prevent health disparities.

Public health relevance
Narrative Disasters create widespread disruption across all societal systems. Low income and racial and ethnic minoritized people populations experience disproportionate burden of disasters due to historical policies that house some population groups in riskier areas, experiencing greater disaster risk and exposure. This project will describe neighborhood changes associated with climate related disasters and link these changes to longitudinal measures of cognitive impairment in order to identify markers of community resilience that mitigate changes in cognitive outcomes.